Translational Research Support Core

SUMMARY: TRANSLATIONAL RESEARCH SUPPORT CORE
The vision for the Translational Research Support Core (TRSC) of the Gulf Coast Center for Precision
Environmental Health (GC-CPEH) is to improve environmental health and advance equity by promoting
translation of laboratory-based research into population studies and facilitating “reverse translation” of work in
community and clinical settings into new hypothesis-driven research. The TRSC leverages resources and talent
from GC-CPEH parent institutions and supports translational environmental health sciences (EHS) research in
three Thematic Focus Areas: Genome and Epigenome Environment Interactions (GE2); Mechanisms and
Interventions for Human Environmental Disease (MIHED) and Current and Emergent Environmental Threats
(CEET) to human health. The TRSC provides centralized expertise, resources, and capabilities, combined with
seamless access through the TRSC Web portal, and supports workshops and symposia that increase the
environmental health impact of GC-CPEH members. Translational Navigators provide subject matter expertise
and prioritized access to TRSC resources and capabilities, and the Matching Funds Core Utilization Program
increases cost-effectiveness and utilization of TRSC services. The TRSC creates powerful synergy with other
components, including: 1) the Thematic Focus Areas by promoting forward and reverse translation of member
research; 2) the Pilot Project Program by providing guidance and capabilities for translational research
approaches into pilot project applications; and 3) the Administrative Core through tracking of member usage and
outcome metrics, surveys for service and capability needs, subsidies from the Matching Funds Core Utilization
Program, and participation in the Leadership Development Program. As a bridge between bench- and
population-based researchers, the TRSC promotes and sustains collaborations that contribute to high- impact
publications and acquisition of extramural grants supporting EHS research. Working with the Community
Engagement Core (CEC), the TRSC facilitates forward and reverse translation of member research with
community partners and policy makers to improve environmental health. The TRSC and CEC cooperatively
provide strategic support for research, educational and outreach activities on emerging health threats,
particularly among health disparity populations. Specific Aims for the TRSC are: Specific Aim 1: Provide
services and resources that foster translation between laboratory-based and
clinical and population health research; Specific Aim 2: Enhance translational EHS research by members via
integration with other GC-CPEH components and facilitating impactful collaborations; Specific Aim 3: Enhance
basic and population based translational EHS research by facilitating interactions between researchers and
community partners and supporting the Plan to Enhance Diverse Perspectives (PEDP).